Mississippi INBRE

The Mississippi IDeA Network of Biomedical Research Excellence (MS INBRE) is a statewide network dedicated to enhancing biomedical research at all institutions of higher education in Mississippi. The overall goal of the network is to build the biomedical research workforce needed to address poor health outcomes in MS by improving leadership and increasing access to resources. With this goal in mind, the MS INBRE has developed its activities around three scientific themes that disproportionally impact Mississippians: cancer, infectious disease, and obesity. MS is ranked second lowest in the United States in terms of access to healthcare, primarily owing to the state’s small economy and historically low investment in health care infrastructure. This is mirrored in the biomedical research infrastructure, which has lagged in comparison to other states. The result is a vicious cycle in which it is more difficult to make improvements in health care access and outcome variability. This makes investments, embodied by the MS INBRE program, key to improving the biomedical infrastructure at partner institutions that provide the education and training to Mississippi communities. The following aims have been developed to accomplish the overall goal of the MS INBRE: 1) Improve research capacity at Primarily Undergraduate Institutes (PUIs) in Mississippi; 2) Build collaboration among academic scientists and community-based organizations; and 3) Develop a skilled workforce in biomedical research and health-related careers. At the completion of the proposed project, we will strengthen the competitiveness of Mississippi in biomedical research by improving infrastructure, enabling research at undergraduate institutions, and training students that address the needs of Mississippians.

Public health relevance
: The Mississippi INBRE is designed to improve biomedical research in the state and positively impact student training. This will be accomplished by 1) supporting the research enterprise at primarily undergraduate institutions, 2) promoting collaboration among biomedical researchers, and 3) by training students in biomedical research and increasing the health-related career workforce. OVERALL